The interplay of the immune system, and microbiome in determining outcome of respiratory viral infections in hematopoietic cell transplant recipients and in patients with leukemia

ABSTRACT
The role of the complex interplay of the nasopharyngeal microbiome, including the virome, and the systemic or local immune response in predicting complications from respiratory viral infections (RVIs) and their outcomes in immunocompromised patients, remains unknown and needs to be determined. The long-term goal is to identify host immunologic factors and respiratory microbiome changes during RVIs that are associated with poor outcome, mainly lower respiratory tract infection (LRTI), death, or pulmonary impairment (PI) in hematopoietic cell transplant (HCT) recipients, and in patients with leukemia. The overall objective of this proposal is to identify host and pathogen factors as predictors of poor outcome in a high-risk population of cancer patients with RVIs. Based on preliminary findings, our central hypothesis is that dysbiosis between respiratory viruses and the microbiome, in conjunction with specific immune response elements, could act as a trigger or cofactor for poor outcome in RVIs. Building on the investigators’ expertise, the study hypothesis will be tested through the following two specific aims. Aim 1: To determine whether serial changes in the respiratory microbiome and virome resulting from RVIs affect the overall survival (OS) at 1 month, 3 months, progression free survival (PFS) at 12 months, and the risk of progression to LRTI, and PI in HCT recipients and in patients with leukemia. Sub-aim 1.1: To identify novel or undiagnosed viruses in HCT recipients with respiratory symptoms but negative routine molecular viral diagnostic tests. Sub-aim 1.2: To characterize variations in the microbiome/virome based on geography (US and Brazil) after RVIs in HCT recipients and in patients with leukemia. Aim 2 To de-fine systemic and local immune responses after RVIs in HCT recipients and in patients with leukemia to deter-mine whether an association exists between immune profiles and worse outcomes such as OS at 1 month, 3 months, PFS at 12 months, and progression to LRTI, and PI. The research design will be a prospective multi-site cohort study between two sister institutions, The Univ. of Texas MD Anderson Cancer Center in Texas, US, and the A.C. Camargo Cancer Center in Sao Paulo, Brazil. Methods: Nasopharyngeal microbiota profiles of patients with RVIs will be achieved by next-generation sequencing (NGS). In parallel, RVI-induced host immune responses will be investigated using high parameter flow cytometry of cellular immune profiles (peripheral blood), as well as multiplex analyte detection of immune mediators using a bead detection platform (blood and nasal wash). The contribution of the proposed research will provide a comprehensive understanding of risk factors, including the interplay of microbiome changes and host immune responses, for progression to poor outcome after RVIs in a high-risk population. This application is innovative as it represents a new and substantive departure from the status quo by shifting focus from epidemiological studies to metagenomics NGS and to generation of high dimensional local and systemic immune profiles, on outcome in RVIs in this vulnerable population. This original approach will lead to broader understanding of pathogenesis and to better diagnostic tools and treatment strategies to improve outcome in immunocompromised patients

Public health relevance
Project Narrative The proposed research is relevant to public health because it will increase our knowledge about the risk factors for progression to poor outcome after respiratory viral infections in a very high-risk population at a host-pathogen interaction level. The project is relevant to the part of the National Cancer Institute’s mission pertaining to supporting cancer research across the nation to advance scientific knowledge and help people live longer, and healthier lives since we anticipate reaching new research horizons in interventions to prevent severe complications after respiratory viral infections by targeted and personalized medicine. In addition, personalized approaches that have been previously unattainable through epidemiological studies are also likely to become attainable.